Systems biology to predict progression and treatment response in M avium complex pulmonary disease

PROJECT SUMMARY
Prevalence of pulmonary disease due to non-tuberculous mycobacteria in the United States has doubled in the
last 10 years, and Mycobacterium avium pulmonary disease (MAC-PD) is the most common. Treatment requires
≥3 antibiotics for >12 months and efficacy remain low. Given this intense treatment regimen and limited efficacy,
antibiotic therapy is not always advisable. In fact, ~50% of patients will attain culture conversion with observation
alone or with bronchial hygiene treatments. There is currently no way to predict which patients will improve with
or without antibiotic treatment. The result of this uncertainty is prolonged ineffective treatment which risks side
effects, drive drug resistance and extend treatment duration. We propose an interdisciplinary approach that
combines clinical, immunological and pharmacological data. We will integrate these datasets from retrospective
and prospective cohorts using machine learning and mechanistic computational simulations with the goal of
developing a disease progression risk score (DP-RS) for patients managed without antibiotics (Aim 1), and a
treatment failure risk score (TF-RS) for patients treated with guidelines-based antibiotic regimens (Aim 2). Such
risk scores can help to predict patients at risk of disease progression without antibiotics or treatment failure with
antibiotics, so they can be prioritized for closer observation or intensified treatment, respectively.
For patients who do not receive antibiotics (Aim 1) we will a) use retrospective clinical data from Indiana, Florida
and Minnesota to train and test random forest algorithms to predict disease progression and validate our predic-
tions against prospective clinical cohorts from Florida and Minnesota; b) identify antigen specific T cells re-
sponses associated with disease progression; c) predict tissue-level disease progression based on patient-spe-
cific T-cell responses using mechanistic computational models; and d) train and test simulation assisted random
forest (SARF) algorithms that integrate clinical, immunological and computational data to predict disease pro-
gression and derive the DP-RS.
For patients who receive antibiotics (Aim 2) we will a) use retrospective clinical data (Indiana, Florida, Minnesota)
to train and test random forest algorithms to predict treatment failure and validate our predictions against pro-
spective clinical cohorts (Florida, Minnesota); b) identify antigen specific T cells responses associated with treat-
ment failure; c) identify serum and bronchoalveolar lavage pharmacokinetics associated with treatment failure;
d) predict tissue-level treatment response based on patient-specific T-cell responses and pharmacokinetics us-
ing mechanistic computational models; and d) train and test SARF algorithms that integrate clinical, immunolog-
ical, pharmacological and computational data to predict treatment failure and derive the TF-RS.
Together, this work will provide fundamental insights into clinical, immunological and pharmacological contribu-
tors to MAC-PD disease progression and treatment response, as well as provide predictive risk scores (DP-RS
and TF-RS) that will translate into precision medicine management tools, helpful for clinicians and patients.

Public health relevance
PROJECT NARRATIVE Pulmonary disease due to non-tuberculous mycobacteria, including Mycobacterium avium Complex Pulmonary Disease (MAC-PD), is increasing worldwide, and treatment remains challenging because a) some patients will improve without antibiotics, while b) not all patients that receive antibiotics will recover. We will leverage existing clinical data, together with newly collected clinical, immune and drug data, to predict which patients are likely to get better with or without antibiotics by using a combination of computational tools (machine learning (top-down) and mechanistic (bottom-up) models). This work will help us understand how bacteria, host immune response and antibiotics work together to drive infection outcomes; but also provide predictive tools that will improve clinical management and treatment outcomes for MAC-PD patients by determining patient-specific risks for different treatment strategies.